Hypoxia: Molecular Mechanisms of Oxygen Sensing and Response Pathways

DESCRIPTION (provided by applicant): This proposal is to request support for a Keystone Symposia meeting entitled "Hypoxia: Molecular Mechanisms of Oxygen Sensing and Response Pathways", organized by Navdeep S. Chandel, Peter J. Ratcliffe, Volker H. Haase and Agnes G"rlach, which will be held in Keystone, Colorado from January 19 - 24, 2010. Molecular oxygen is absolutely essential for cellular respiration and higher organisms have developed sophisticated physiological responses that allow adaptation to a low oxygen environment. These include neurotransmitter release from the carotid body to increase respiration;pulmonary vascular constriction to redirect blood flow from poorly to well oxygenated regions;and in the kidney, enhanced erythropoietin secretion to boost red blood cell production to augment oxygen carrying capacity. Tissue hypoxia is not only associated with a variety of pathological conditions such as pulmonary, cardiovascular and neoplastic diseases, but also occurs during normal embryonic development and plays an important role in stem cell maintenance. This meeting will highlight the latest, cutting-edge advances in hypoxia research and discuss (1) the cellular and molecular mechanisms that underlie physiological responses to hypoxia, (2) the role of hypoxic signaling in the pathogenesis and progression of pulmonary hypertension, ischemia and cancer, (3) the importance of hypoxia in stem cell maintenance and embryonic development, and (4) the overall state of the art in hypoxic signaling in inflammation and metabolism. (End of Abstract)

Public health relevance
PROJECT NARRATIVE Cellular responses to hypoxia have profound effects on normal processes like embryonic development and stemcell maintenance as well as diseases such as pulmonary hypertension, inflammation, cancer and ischemia. The 2010 Keystone Symposia meeting on Hypoxia: Molecular Mechanisms of Oxygen Sensing and Response Pathways brings together hypoxia-interested investigators who work on diverse topics such as metabolism, inflammation, stem cells, and cancer. Molecular mechanisms and hypoxic signaling pathways - which offer great potential for therapeutic exploitation - will be discussed, as will novel therapeutic approaches for the treatment of different diseases, such as pulmonary hypertension, ischemia, and cancer.